Community Engagement Core

Community engaged participatory research (CBPR) is defined as the process of working collaboratively
with groups of people affiliated by geographic proximity, special interests, or similar situations affecting their well-
being. Dissemination of research findings with stakeholders and community members is a significant part of
CBPR as it relates to the GCCCR Community Engagement Core (CEC). CBPR requires effective communication
between researchers and stakeholders. Bidirectional communication is essential for any community-focused
research or intervention to ensure a functional, successful collaboration. This CBPR principle holds true for
environmental health and dissemination of research findings in a community setting. To build a trusting
collaborative relationship between community members and researchers, bi-directional dialogue must be
established. Community Health Workers (CHWs) are frontline public health workers who have a close
understanding of the communities they serve. Volunteer Peer Health Advocates (VPHAs) are trained volunteers
who are committed to improving the health of their communities. Establishing relationships between CHWs,
VPHAs and community members creates mutual respect, enabling bidirectional dialogue between communities
and researchers, thus laying the foundation for ongoing, symbiotic collaboration. Leveraging what CHWs and
PHAs learn from constant engagement with community members will help researchers identify areas for further
investigation. This collaboration enables CHWs and VPHAs to serve as liaisons and intermediaries between
health care and social service systems. An advisory board will facilitate bidirectional communication between
researchers and stakeholders within the specified GCR communities. The board will serve as the primary
resource for developing and conducting environmental health literacy training as well as facilitating town hall
meetings to serve as a key platform for increasing awareness, building trust, and disseminating research findings
and information. Further, the CEC will utilize existing CHWs and VPHAs to assist in the identification and
recruitment of key community members to participate in formative research including a baseline environmental
health assessment to determine communities’ needs, knowledge, resources, strengths, and limitations. This
information will be used to identify collaborations and develop appropriate environmental health education and
training to reduce barriers and effectively achieve these goals. In addition to town hall meetings, the CEC will
develop a social media page to use as an effective tool in research dissemination and bidirectional commination
between the community members and researchers. An electronic newsletter will feature research updates,
research findings, and announce opportunities for community members to participate in active research. The
electronic newsletter will be distributed to stakeholders, community organizations, local health departments, faith
based organizations, community based organizations, and community members.